Core-002

Community Engagement (CE). The CCTSI places a high priority on engaging community members and other
stakeholders in the full spectrum of clinical and translational research (CTR). The Community Engagement and
Research (CE&R) Core will include a portfolio of innovative programs and relationships including a nationally
recognized Pilot Grant Program. The Core has demonstrated the value and benefits of engaging patients and
communities as active partners in research to address community priorities, design studies in a culturally-sensitive
and participant-friendly structure, implement and disseminate findings into the community, and enhance
public trust and participation in research. The CE&R Core will broaden the stakeholders with whom it engages
and further integrate CE&R throughout the CCTSI, increase the bi-directional nature of its work, and integrate
engagement work with that of its partners in team science at the University of Colorado (CU), Colorado State
University (CSU), hospital partners, and the CTSA Consortium. To achieve these goals, the following Specific
Aims are proposed: Aim 1: Expand the community stakeholders to include an array of healthcare organizations
and payers to expand the potential for implementation and dissemination. Aim 2: Further infuse Community
Engagement throughout the translational spectrum within all CCTSI programs and operations. Aim 3: Increase
capacity for bi-directional engagement between researchers and community stakeholders to enhance the
science of community engaged translational research.
Collaboration and Multidisciplinary Team Science. The CCTSI has invested in the advancement of team
science through incentives (e.g., leadership training in team science, team science pilot grant awards) that bring
together investigators across different scientific disciplines and across different levels of the translational
research spectrum to conduct innovative CTR. This Core will enhance and expand these programs by advancing
the integration of community stakeholders in CTR research teams and by building a new Science of Team
Science (SciTS) program. The SciTS program will be scaled up from activities first developed and evaluated at
CSU. The overarching goals are to foster an environment that values team science research and to develop and
evaluate evidence-based research team-building activities that enhance the success of research teams through
the following Specific Aims: Aim 4: Catalyze translational collaboration and team science training and the
engagement of community stakeholders with research teams. Aim 5: Implement a SciTS academic program to
enhance the science and success of multidisciplinary research teams.